Developmental exposure to lead and noradrenergic regulation of the acute stress response

PROJECT SUMMARY
Anxiety and depression are stress-related disorders afflicting at least a quarter of the world’s population and
imposing an enormous economic burden on societies. These disorders are highly comorbid owing to the fact
that both stem from disruptions in the stress circuitry. An appropriate stress response relies on the proper
development and functionality of noradrenergic (NA) signaling. Disruptions in this system can lead to behavioral
alterations, which can onset or aggravate stress-related psychiatric disorders, including pathological anxiety and
depression. Genetic susceptibility does not fully explain individual vulnerability, and thus, the environment is
likely a significant factor contributing to their development. Developmental exposure to lead (Pb) affects a third
of children worldwide and is associated with stress-related behavioral disorders. Despite the increasing incidence
of these disorders, a significant gap exists in our understanding of the mechanisms underlying Pb-induced
alterations in stress responses.
The central aim of this study is to examine the role of NA signaling and its chief regulator, the locus coeruleus
(LC) NA neurons, in mediating Pb-induced stress behavior phenotypes. Our preliminary investigations
demonstrate aberrant stress responses for only trace Pb exposures, and pharmacological modulation of NA
signaling can recapitulate Pb-induced behavioral phenotypes. Therefore, we hypothesize that early
developmental exposure to Pb induces stress pathologies by disrupting NA signaling through its chief regulator,
the LC/NA neurons. We will test this hypothesis through two specific aims: 1) To delineate the role of Pb-
induced aberrant NA signaling in the propagation of altered stress responses and 2) To uncover the structural
and functional changes by which early developmental Pb exposure alters the sensitivity of LC/NA neurons to
subsequent stressors and Pb accumulation within this group of neurons. This R21 exploratory grant promises
crucial insights into the overlooked role of Pb-induced insults to neuronal populations regulating the acute stress
response, paving the way to more targeted therapeutic and mitigation strategies. It will also generate models
readily adaptable for broader applications, encompassing other neuronal populations, environmental
contaminants, or stressors. This project leverages the genetic tractability, transparency, and extrauterine
development of the zebrafish model, along with cutting-edge technologies, to observe neural changes in the
brain and their behavioral correlates non-invasively.

Public health relevance
PROJECT NARRATIVE This study leverages the zebrafish model to investigate the effects of developmental lead (Pb) exposure on a key regulator of the stress response, aiming to elucidate its contribution to Pb-induced stress behavioral phenotypes. Through genetic and pharmacological modulations, we intend to establish a causal link between noradrenergic signaling disruptions and behavioral changes induced by Pb, and to reveal structural and functional changes in the noradrenergic neurons of the locus coeruleus via transgenesis and in vivo brain imaging. Considering that stress-related psychiatric disorders affect a quarter of the global population, and environmental contaminant exposure is a significant yet underexplored risk factor, our research will provide valuable insights into the intersection of environmental toxicology and mental health.